CRCNS:NeuroBridge: Connecting Big Data for Reproducible Clinical Neuroscience

In replication, mega analysis, and meta-analysis that are critical to the advancement of neuroimaging
research, a critical question is how to harness already-collected data for replication purposes efficiently and
rigorously. Much of the present efforts on reproducibility science assumes that appropriate datasets are
available. While many different neuroimaging databases exist, they have different languages, formats, and
usually do not communicate with each other. Moreover, neuroimaging data are collected in hundreds of
laboratories each year, forming the “long tail of science” data. Much of this data are described in journal
publications but remain underutilized. A critical gap therefore exists in getting enough data of the right kind
to the scientist. We propose the NeuroBridge, a data sharing infrastructure that combines innovative
techniques and established technologies in a platform that will greatly enhance the reuse of critical
neuroscience data sets.
RELEVANCE (See instructions):
Our research develops technologies that address critical gaps in big data clinical neuroscience research.
Our proposed research includes collaboration with addiction projects such as COINSTAC and ENIGMA-
addiction. These efforts will leverage technologies that can “expand access to increasingly larger
databases … along with rapid advances in analytic, computational, and information technologies,” and
increase scientific rigor and reproducibility that will lead to “improved quality and credibility of addiction
research and advancement in research on drug use and addiction,” key cross-cutting themes of the
National Institute on Drug Abuse (NIDA). Moreover, our focus on developing advanced informatics tools for
“Big Data and Computational Science” is in direct alignment with the goals of the Division of Neuroscience
and Behavior (DNB) with NIDA. Our above proposed collaborations can further the NIDA mission of
“identifying the neural circuits underlying drug addiction and their functional properties,” and “the causes
and consequences of drugs of abuse and addiction across the lifespan and to guide treatment strategies.”